MicroRNAs regulate skin Langerhans cells

Abstract
Langerhans cells (LCs), the skin residing dendritic cells (DCs), control both the induction of
adaptive immunity, and immune tolerance in skin and are involved in variety of skin disease
development. However, the regulatory mechanisms involved in the development and functions
of LCs have not been completely elucidated. MicroRNAs (miRNAs), a class of non-coding small
RNAs, are recognized as important regulators of protein-coding genes through the inhibition of
mRNA translation. Using Cre-loxP Dicer deletion mouse models, our laboratory and others have
reported that deletion of miRNAs by CD11c-Cre or hLangerin-Cre significantly reduced the
number and interrupted the function of LCs, indicating that miRNAs are required for LC
homeostasis and function after birth. While there are more than 1000 experimentally reported
miRNAs, very few individual miRNAs are linked to LCs so far. We were the first to report that
miR-150 and miR-223 differentially regulated LC-induced T cell proliferation and cytokine
production. Most recently, our embryonic lineage-tracing studies showed that miRNAs, including
miR-17-92 cluster, regulate LC embryonic development. Furthermore, using miRNA arrays, we
identified that mature LCs have a unique miRNA gene expression profile compared to immature
LCs, and that miRNA expression is dynamically changed during LC embryonic ontogeny. These
findings led to our central hypothesis that the dynamically changed miRNAs may serve as
critical regulators controlling LC ontogeny, homeostasis and function through fine-tuning specific
target genes. In Aim 1, we will investigate the roles of miRNAs in LC ontogeny and homeostasis.
Constitutive or inducible Csf1r-specific individual miRNA mutant mice will be used for studying
embryonic LC ontogeny and LC repopulation after inflammation, while LC-specific Dicer or
individual miRNA mutant mice will be used for LC homeostasis after birth. In Aim 2, we will
investigate the roles of miRNAs in LC function, inducible LC-specific Dicer or individual miRNA
mutation mouse models will be used. In Aim 3, the direct target gene(s) of miRNAs and related
signaling pathways involved in LC development and function will be investigated by the
combination of RNA-seq, miRNA bioinformatics and related target functional validation
strategies. The proposed studies will uncover the dynamic miRNA-mRNA regulation and related
molecular mechanisms and signaling pathways that control LC development and function, which
will not only provide new insight into the biology of LCs, but may also facilitate the development
of LC-based intervention strategies for diseases.

Public health relevance
Project Narrative Langerhans cells (LCs), the skin residing dendritic cells that form a contiguous immune network in skin, are involved in a variety of skin disease development. But the detailed molecular pathways regulating LC development and function remain largely unknown. MicroRNAs (MiRNAs) are small, non-coding RNAs that regulate gene expression through inhibiting protein translation. Our previous studies have shown the potential involvement of miRNAs in regulating LC development and function. The overall goal of this proposal is to investigate the role of individual miRNAs and related molecular mechanisms in regulating LC development, maintenance and function. The proposed studies will not only provide new insight into the biology of LCs, but may also facilitate the development of LC-based novel intervention strategies for disease treatment.